An Integrated In Silico and In Vivo Genetic Screening Approach to Identify Subtype-specific Hepatocellular Carcinoma Genetic Dependencies

PROJECT SUMMARY/ABSTRACT
Hepatocellular carcinoma (HCC) is the 5th leading cause of cancer worldwide and the 4th leading cause of cancer-
related mortality. Patients who present with advanced disease have poor prognosis, and currently approved
systemic therapies confer only modest survival benefit. While HCC is a heterogeneous disease with subtypes
marked by distinct clinical and pathomolecular features, precision therapies are currently lacking. In recent years,
with the emergence of clinical trials for HCC targeted therapy, tissue biopsies are being increasingly utilized,
presenting a timely opportunity to develop novel precision therapeutic approaches. However, most known
molecular drivers of HCC remain pharmacologically difficult-to-target. Identifying targetable dependencies
(genes essential for cancer cell proliferation) for HCC subclasses based on pathomolecular features thus
represents a promising therapeutic strategy. We have previously developed a deep learning model to predict
genetic dependencies based on multi-omic tumor profiles, and my preliminary work suggests that this model can
predict dependencies specific to mutational subsets of HCC patients. Further, our group has developed murine
models representing subtypes of HCC according to the Hoshida classification system (S1, S2, and S3). Given
my preliminary observations, I hypothesize that genetic dependencies of HCC demonstrate subtype specificity
based on pathomolecular features. I will address this hypothesis using a hybrid in vivo and in silico approach via
the following specific aims. Specific Aim 1 (in vivo): I will determine whether dependencies predicted via deep
learning demonstrate subtype specificity using in vivo loss-of-function screening and subsequently quantify the
effect on tumor burden with single gene knockout of the most specific dependency for each subtype. This will
enable efficient identification of potentially targetable, subtype-specific dependencies in robust preclinical
models. Specific Aim 2 (in silico): I will expand the scope of our existing deep learning model to predict genetic
dependencies from hematoxylin and eosin (H&E) images, after which I will compare the abundance of predictive
H&E features across Hoshida subtypes to determine the subtype specificity of these features. I expect this to
reveal novel, subtype-specific H&E features which predict HCC dependencies. These related but distinct and
independent aims will contribute to our understanding of subtype-specific vulnerabilities in HCC, laying the
groundwork for a theranostic pipeline to identify targetable dependencies based on patient-specific
pathomolecular features. Through hands-on experience, mentorship, clinical exposure, conferences,
coursework, and other activities described in my training plan, the education supported through this fellowship
will prepare me for an impactful career as a physician-scientist at the forefront of digital pathology and precision
medicine efforts.

Public health relevance
PROJECT NARRATIVE Hepatocellular carcinoma (HCC) is a leading cause of cancer incidence and mortality worldwide, with poor prognosis for patients with advanced disease and limited survival benefit conferred by currently approved systemic therapies. In recent years, with the emergence of clinical trials for HCC targeted therapies, tissue biopsies are being increasingly utilized, presenting a timely opportunity to pioneer novel precision therapeutic approaches. The proposed studies will use an integrated in vivo and in silico strategy to investigate subtype- specific HCC genetic dependencies, towards the goal of developing a theranostic pipeline for identifying targetable dependencies based on patient-specific pathomolecular features.